Contribution of child development, biological aging, and beta-amyloid to cognitive function of the Louisville twins at midlife

Project Summary/Abstract
The overarching aim of our current funding (NIH Grant # R01 AG063949-01) is to repurpose the Louisville Twin
Study’s original goal of understanding the etiology of child cognitive development into a true lifespan
developmental twin study of cognition, including delineation of the etiology of preclinical symptoms of
Alzheimer’s disease and related dementias. In the current project period, the third independent aim
encompasses modeling effects of cognitive development on cognitive functioning in midlife, adjusting for
confounding genetic and environmental factors. Throughout the life of the Louisville Twin Study (LTS),
however, recorded ability scores have been age standardized, thus making it impossible to estimate effects of
true intraindividual change in cognitive ability over any period of development. Problems with the age-
standardized approach are compounded by the administration of different tests (e.g., moving from the
Wechsler Intelligence Scale for Children (WISC) to the Wechsler Adult Intelligence Scale (WAIS)) and test
editions (e.g., updating from the WAIS-III to the WAIS-IV) that supposedly measure the same latent cognitive
abilities. Whether they actually do so is an empirical question that has not been addressed previously in any
longitudinal twin study of cognitive ability. All LTS twins’ cognitive ability protocols are available, so individual
items could be used in future analyses. We propose using vertical linking methods that allow the administration
of validated cognitive tasks without requiring age-standardizing cognitive test scores. Child and adult test
content typically is not the same, but there are some items that were administered in childhood that can be
retained in adult tests. For the current data collection, three age-appropriate items from the WISC Block
Design, Similarities, Vocabulary, Arithmetic, and Information subtests will be administered to all returning LTS
adults (projected N = 750). As children, LTS twins completed approximately 10 cognitive ability tests, on
average, half of which were WISC tests. With an estimated five WISC protocols administered to each twin, on
average, there are greater than 73,000 individual subtests to archive and vertically link child and adult
Wechsler ability scores. Item Response Theory models subsequently can be used to place ability scores on
the same scale so that ability trends can be studied and compared across different periods of child and adult
development. Twins’ latent cognitive ability test scores, thus, will be put on the same scale from age 7 through
midlife. Our efforts in the LTS are the first of its kind in longitudinal twin studies of cognitive ability. By linking
childhood cognitive tests to adult tests, we will increase the significance and innovation of our findings by
specifying the lifespan growth functions of ability at the subtest and latent factor levels to model individual
twins’ true intraindividual cognitive ability trajectories.

Public health relevance
PROJECT NARRATIVE The biological determinants of Alzheimer’s disease and related dementias (ADRD) are established decades before clinical symptoms of cognitive decline, memory loss and functional decline are observed. As age is the most reliable predictor of ADRD, the proposed study will test whether biological age, as opposed to chronological age, predicts higher levels of preclinical AD biomarkers, as measured with a highly reliable plasma beta-amyloid (Aβ) marker, and whether Aβ accumulation contributes to cognitive decline in midlife in a well-established longitudinal twin sample, the Louisville Twin Study. The nature of this twin design will inform causal pathways between early life development, biological age, Aβ, and cognitive functioning at midlife, shedding light on genetic and environmental mechanisms that promote risk and resilience of preclinical AD.